Core A: Administrative Core

ADMINISTRATIVE CORE REVISED SUMMARY
The Administrative Core will administer and lead the P01, including the other four Cores and the four Projects. The Administrative Core is led by TIME-AD MPIs, with additional support from an Executive Committee comprised of co-Investigators from across TIME-AD institutions. The Core will coordinate the complex project to optimize use of common resources and results; ensure good communication; promote the scientific priorities of rigorous prevention research, and reproducible methodology; and disseminate results to relevant stakeholders. The Administrative Core will engage in the proactive monitoring of projects via a project dashboard, annual planning meetings, monthly Executive Committee meetings, biweekly Administrative Core leadership meetings, and other regular meetings within and across Projects. These activities will ensure progress on the aims of the P01, including the development of the scientific teams, the implementation of rigorous analyses, and translation from data to evidence via dissemination. As part of these responsibilities, the Administrative Core will communicate with the NIA, including providing progress reports and less formal updates on our accomplishments or any challenges that arise. The Core will set standards for authorship, collaboration, decision-making, and resource sharing. Finally, the Administrative Core will be charged with recruiting and supporting early career scholars who are currently affiliated with TIME-AD (e.g. the 11 co- Investigators who are Early Career Investigators) or who will become affiliated over the study period. These mentoring activities will be supported by a dedicated Project Manager as well as the many initiatives that
TIME-AD MPIs and co-Investigators are already involved with, including T32s, training-focused R13s and R25s, and PhD programs. The Administrative Core Aims are to: 1) provide leadership for the P01 and direction for its activities; 2) monitor timely progress, fidelity, quality, and effectiveness of operations of all Projects and Cores and conduct all reporting activities; 3) maintain strong relationships through regular communication with everyone involved in the project; 4) convene the External Advisory Board meetings; and 5) foster connections with related Projects, including training and research initiatives, and chart the future projects and priorities for the TIME-AD investigator community. The Administrative Core will also play a key role along with the Maximizing Population Impact Core in overseeing the dissemination of pertinent findings both internally and externally, to relevant constituencies. In collaboration with Projects and Cores, we will have progress benchmarks, including development of data sets, development of analytic code, preparation of publications, and dissemination of results via peer-reviewed publications, scientific conferences, code-sharing platforms, and beyond, including professional organizations, popular media, and other mechanisms to reach the general public and non-scientists.